Mechanisms of Clinical and Hemodynamic Response to Pulmonary Vasodilator Therapy in Fontan physiology

PROJECT SUMMARY/ABSTRACT
Congenital heart disease (CHD) is the leading cause of cardiovascular death in people less than 50 years of
age, and most of the premature cardiovascular deaths occur in people with complex CHD. Although the Fontan
operation is an effective palliation for complex CHD, it creates a unique physiology characterized by systemic
venous congestion and end-organ dysfunction, which leads to premature death from circulatory failure (median
survival ~40 years). One of the mechanisms leading to this suboptimal outcome begins with impaired nitric
oxide signaling, leading to endothelial dysfunction and pulmonary vascular disease (PVD), and in turn, end-
organ dysfunction and death. The therapeutic benefits of chronic pulmonary vasodilator therapy for PVD in
people with Fontan palliation have not been consistent across trials, and this may be related to the lack well-
defined criteria for PVD diagnosis in Fontan physiology, and lack of understanding regarding the underlying
mechanisms. Recent data show that assessment of pulmonary vascular reserve during exercise improves
detection of PVD, and that impairment in pulmonary vascular reserve correlates with severity of endothelial
dysfunction and end-organ dysfunction. However, it remains unclear whether pulmonary vasodilators can
improve pulmonary vascular reserve in these patients, or what the mechanisms might be. Such data will be
critical for the development novel therapies for prevention and treatment of end-organ dysfunction due to PVD,
an important risk factor for mortality in the Fontan population. The long-term goal is to delay the onset of end-
organ dysfunction and mortality from systemic venous congestion, through early diagnosis and treatment of
hemodynamic derangements in Fontan physiology. The overall objective for this application is to determine the
mechanisms by which enhancement in nitric oxide signaling might improve pulmonary vascular reserve and
end-organ function in Fontan physiology. The central hypothesis is that enhancement in nitric oxide signaling
through treatment with phosphodiesterase-5 inhibition (PDE5i) will improve pulmonary vascular reserve, and
endothelial and end-organ function. This hypothesis will be tested by pursuing two specific aims: (1) Determine
the mechanism of response to pulmonary vasodilator therapy in Fontan physiology; (2) Determine the
mechanism of improvement in end-organ function, aerobic capacity and quality of life (QOL) outcomes after
pulmonary vasodilator therapy. For the first aim, 80 subjects will be randomized 1:1 to PDE5i or placebo, and
invasive exercise test and peripheral artery tonometry will be performed before and after 52 weeks of therapy.
For the second aim, multi-domain outcome assessment (liver, kidney, gut, aerobic capacity, and QOL metrics)
will be assessed before and after therapy. This proposal is innovative and significant as it will delineate the
mechanism of response to pulmonary vasodilators, and in turn, enable targeting of these mechanisms with
current and novel therapies to delay the onset of end-organ dysfunction and circulatory failure.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because identification of the mechanism by which pulmonary vasodilators improve organ function in people with prior Fontan operation, will help inform improved prevention and early treatment strategies for end-organ dysfunction, which in turn, will save lives, reduce morbidity, and reduce healthcare costs. Successful completion of the proposed research in this application will provide evidence-based proof of principle for future clinical trials to determine the benefits of pulmonary vasodilators patients with clinically proven pulmonary vascular disease based on pulmonary vascular reserve. The proposed research is relevant to the NIH’s mission pertaining to the pursuit of knowledge to extend healthy life and reduce the burdens of illness and disability.